Aging and transplant immunity

OVERALL – SUMMARY/ABSTRACT
With an ever increasing aging population and prolonged life spans, there has been a significant increase in the
number of older transplant recipients. At the same time, older patients represent the fastest growing cohort
waiting for a transplant. Those older patients are treated in the same way as young recipients, yet their
alloimmune responses differ substantially. There is thus a significant unmet need to provide treatments for older
transplant recipients that are based on a solid understanding of age-specific changes in alloimmunity. However, that
cannot be done until cellular and humoral mechanisms regulating alloimmunity in aging are fully elucidated. The
unmet need to conduct studies such as those proposed in this PPG is further stressed by: A) our extensive data
indicating that immunoregulation controlling allo-specific responses is distinct in aging, B) that established transplant
immunosuppression has been designed for a youthful immune system with an exclusion of older recipients from the
vast majority of clinical studies, and C) that current immunosuppression strategies are not fully effective in older
individuals and predisposes them to undesired effects. Indeed, our collected data indicate that the current aged-
related immunosuppressive paradigm is overly simplistic and does not recognize important heightened
inflammatory features of aging alloimmunity. Our overall hypothesis is that cellular senescence in fibroblastic
reticular cells (FRCs) of lymph nodes induces a maladaptive T and B cell response leading to a dysregulated
alloimmunity in aging. Clinically, this dysregulated immunity results in age-specific effects of established
immunosuppressants. Co-stimulatory agents, although prime candidates for use as immunosuppression in older
recipients due to the absence of nephrotoxic effects, work effectively only in young but not old recipients.. To
this end, our major goals are to fully examine the cellular and molecular mechanisms that drive transplant
immunity in aging. This PPG sets forth a platform that merges three highly synergistic teams (Drs. Abdi, Tullius,
and Sage) with complementary skills and expertise in LN stroma, T and B cell immunity. Project 1 will test the
hypothesis that aged FRCs contribute significantly to the divergent immune responses observed in aged vs.
young mice. Aim 1 will study the mechanisms by which senescence in FRCs regulates alloimmunity in the LN.
Aim 2 will examine the importance of lymphotoxin pathways for transplant immunity in the stroma of aged LN.
Aim 3 will study novel approaches to rejuvenate the aging LN stroma thereby restoring immune tolerance
following co-stimulatory blockade. Project 2 will test the hypothesis that increased age-specific changes in
innate and T cell immunity rewire allorecognition, T cell metabolism, and immunosuppressive targets. As our
corollary hypothesis we submit that cellular senescence augments alloimmunity and that the depletion of
senescent cells improves transplant outcomes in old recipients. In Aim 1, we will delineate the mechanisms by
which aged DCs regulate T-cell alloimmunity. In Aim2, we will delineate age-specific metabolic reprograming of
allo-reactive T cells. In Aim3, we will test age-specific treatments of old recipients with a focus on nano-delivery
of glutamine inhibitors and senolytics. Project 3 will test the hypothesis that aging causes transcriptional
rewiring in Tfh and B cells altering solid organ transplant rejection. Aim 1 will determine how aging alters
transcriptional rewiring in Tfh cells during antibody mediated rejection making them resistant to costimulatory
blockade. Aim 2 will delineate how alterations in developmental stage progression in aging contributes to a
cellular senescence-like pathogenic state in Tfh cells, and Aim 3 will determine how aged Tfh-targeted nano-
therapeutics can alter allo- versus anti-viral immunity in the settings of aging. An Administrative Core (Core A),
Nano-Immune Imaging Core (Core B) , and Microsurgery Transplantation Core (Core C) will provide necessary
support so these three projects accomplish their goals.

Public health relevance
OVERALL –NARRATIVE Organ transplantation has become a gold standard therapy for older patients with end-stage organ diseases. The goal of this proposal is to delineate mechanisms controlling transplant immunity in aging. A better understanding of the mechanisms by which aging affects transplant immunity is crucial for the development of aged specific immune therapies in transplantation.